Mechanisms of disrupted homeostasis and kidney injury

PROJECT SUMMARY
Diabetic Kidney Disease (DKD) is the leading cause of kidney dysfunction and failure for
more than 400 million patients worldwide. While the high prevalence of obesity is closely
linked to the increased incidence of Type 2 diabetes, hypertension, and kidney failure, the
complex interplay between these conditions is incompletely understood.
Our recent work revealed an important role for a specialized group of cells in the kidney
called TREM2 resident macrophages. These cells appear to increase in numbers in both
mouse and human kidneys in the setting of obesity and diabetes. Therefore, the molecule
TREM2 that is found on the surface of these immune cells may be a therapeutic target for
kidney disease.
The goal of this proposal is to build on our recent discoveries and perform detailed studies
in mouse models and human kidney tissue to gain further insight into whether TREM2
macrophages can protect the kidney from the harmful effects of obesity-driven type
2 diabetes. This work will pave the way for new therapies for diabetic kidney disease
patients, which are greatly needed.

Public health relevance
PROJECT NARRATIVE The overall goal of this competitive renewal application is to build on our recent discoveries to gain further insight into the role of a specialized group of cells called TREM2 macrophages in protecting the kidney from the harmful effects of obesity-driven diabetic kidney disease.